Collision of Alzheimers disease and COVID-19 pandemic in the United States: risks, outcomes, disparities and treatments

PROJECT SUMMARY
In this project titled “Collision of Alzheimer’s disease and COVID-19 pandemic in the United States:
risks, outcomes, disparities and treatments”, we propose to: 1) examine COVID-19 risk in patients with
Alzheimer’s disease (AD), consider racial and gender disparity, and follow its evolution over time; 2) examine
new onset of AD in COVID-19 survivors, consider racial and gender disparity, and follow these changes over
time; 3) characterize long-haul neuropsychiatric Post-Acute Sequelae of COVID-19 (Neuro-PASC) in COVID-
19 survivors with AD, consider racial and gender disparity, and follow these changes over time; and 4)
investigate therapeutic effects of Tumor Necrosis Factor (TNF) blockers on overall mortality and long-haul
Neuro-PASC in COVID-19 survivors with AD. To answer these questions, we will utilize a US nation-wide, real-
time database of de-identified electronic health records (EHRs) of 80 million patients (4.8 million confirmed
COVID-19 cases). Our study will primarily focus on over 17 million senior patients age ³ 65 years, including
more than 1 million COVID-19 cases, 265,818 patients diagnosed with AD, and 22,518 patients with both
COVID-19 and AD (as of May 20, 2021). Our study will establish methods for real-time analysis of EHRs of
vulnerable aging population of tens of millions across the USA in examining infectious diseases and their
interaction with existing disorders such as AD, which will allow us to be better prepared should another
pandemic overtake us. The significance of these studies therefore extends beyond the data at hand.

Public health relevance
PROJECT NARRATIVE We propose to characterize multifaceted interactions between COVID-19 and Alzheimer’s disease (AD) based on real-time analysis of electronic health records (EHRs) of over 17 million elderly patients (age ³ 65 years). Our studies will provide insights into AD etiology as well as disease prevention and treatment. Establishing methods for real-time analysis of EHRs of vulnerable aging population of tens of millions across the USA in examining infectious diseases and their interaction with existing disorders such as AD will allow us to be better prepared should another pandemic overtake us.